CART PEPTIDES IN AROUSAL AND SLEEP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The effect of icv injection of CART 55-102 on promoting wakefulness was robust and lasted for up for 4 hours following injection. The effect was not seen with an inactive CART fragment. Moreover, the period of wakefulness was followed by a rebound increase in both NREM and REM sleep. These findings point to a potential novel role for CART in regulating wakefulness.